Influence of Mixed Retrovirus Infections on Leukemia and Neurological disease

The induction of many diseases in mice by murine leukemia viruses (MuLVs), involves the participation of variant retroviruses termed polytropic MuLVs. These include the induction of proliferative, immunological and neurological disorders. Polytropic MuLVs are formed by recombination of exogenous ecotropic MuLVs with endogenous envelope sequences present in the genomes of inbred mouse strains resulting in viruses which utilize a distinct cell-surface receptor for infection. The infectious host range of ecotropic MuLVs is limited to mice;however the recombinant polytropic viruses generated after inoculation of mice with ecotropic MuLVs are capable of infecting a number of other species as well as mice. Thus, the generation of polytropic viruses results in a mixed retrovirus infection of viruses with different infectious properties. Our earlier studies strongly suggest that the interactions of ecotropic and polytropic MuLVs in the host play a role in facilitating oncogenesis. More recently we have investigated the interactions of retroviruses in mixed infections in vivo by co-inoculation of mice with mixtures of polytropic MuLV isolates and ecotropic MuLVs. Mice infected with defined mixtures of retroviruses exhibit dramatically altered pathology compared to infection with the individual viruses of the mixture. These included a highly significant delay in the induction of proliferative disease with one polytropic MuLV and a profound synergistic effect resulting in the abrupt development of a neurological disease with another polytropic isolate. In both instances the polytropic virus load in the co-inoculated mice was markedly enhanced while the level of the ecotropic MuLV was unchanged. Furthermore, the polytropic MuLV was nearly completely pseudotyped within ecotropic virions in co-inoculated mice. There are a number of possible mechanisms which could facilitate the profound in vivo amplification of the polytropic MuLVs including enhanced spread of the virus due to pseudotyping within ecotropic virions or possibly transactivation of the polytropic virus in co-infected cells. In order to study this phenomenon in a less complex setting, we are currently examining mixed retrovirus infections utilizing in vitro cell lines. We have found that mixed infections of in vitro cell lines with ecotropic and polytropic MuLVs results in amplification and pseudotyping characteristics remarkably similar to what we have observed in vivo. Notably, the polytropic MuLV genome is extensively pseudotyped within ecotropic virions and the infectious polytropic virus titer is profoundly elevated in co-infected cells. This observation could have resulted from an increase in the level of polytropic genomes released from the cells. Alternatively, the observed increase could reflect a much higher specific infectivity of ecotropic virions compared to polytropic virions. Further studies strongly suggest that the increase in polytropic virus titer is not due to differences in specific infectivity, but rather to an increase in the efficiency of packaging and release of the polytropic genome in co-infected cells. .